Mechanisms underlying maintenance of cardiac chamber identity in zebrafish

PROJECT SUMMARY
In the vertebrate heart, the atrial and ventricular chambers contain distinct types of cardiomyocytes with
specific molecular, morphological, and physiological properties. Atrial and ventricular specification are thought
to occur in the early embryo, and chamber-specific gene expression patterns are apparent before the heart
tube forms. However, the early assignment of atrial and ventricular cardiomyocyte fates is not sufficient to
ensure commitment to a particular identity: chamber fate decisions seem to be malleable and can be
reversible, even after differentiation initiates. Although the stability of chamber-specific characteristics is
crucial for effective cardiac function, we do not yet understand the mechanisms responsible for maintenance of
cardiac chamber identity. Our research addresses this significant gap in our knowledge by focusing on the
genetic pathways that reinforce ventricular cardiomyocyte identity in the embryonic zebrafish heart. Several
lines of evidence indicate that the ventricular myocardium harbors considerable plasticity: under certain
circumstances, ventricular cardiomyocytes can transform, gradually losing their ventricular traits and
simultaneously acquiring atrial traits. Our recent work has demonstrated that a FGF-MEK-ERK signaling
pathway plays a pivotal role in the maintenance of ventricular identity, enforcing the retention of ventricular
characteristics and suppressing the appearance of atrial characteristics. Building on this discovery, we are
now well positioned to illuminate novel aspects of the mechanistic basis for chamber identity maintenance.
First, we will elucidate the downstream effectors that mediate the impact of FGF-MEK-ERK signaling on the
maintenance of ventricular identity. Our data suggest that dynamic patterns of ERK activation, downstream of
FGF signaling, act cell-autonomously within ventricular cardiomyocytes to regulate transcription factors that
promote ventricular gene expression and repress atrial gene expression, and we will test this model using real-
time biosensors, chimera analysis, and transcriptomics. Second, we will identify factors that confer differential
plasticity within distinct ventricular regions. The inner and outer curvatures of the ventricle differ in their
inherent malleability; these differences may reflect local dynamics of ERK activity, regional distributions of
biomechanical cues, and/or spatially distinct gene expression patterns, and we will test each of these
hypotheses. Third, we will examine whether the signals that maintain ventricular identity in zebrafish play
similar roles in human cardiomyocytes. Using pharmacological and genetic tools, we will test the hypothesis
that FGF-MEK-ERK signaling and its effectors act to reinforce the stability of ventricular cardiomyocyte identity
during differentiation of human pluripotent stem cells in vitro. Overall, our studies are likely to provide novel
insight into crucial and conserved mechanisms that strike a balance between ventricular commitment and
plasticity. Moreover, our results have the potential to inspire innovative strategies for regenerative medicine
and to reveal new perspectives on the origins of congenital heart disease.

Public health relevance
PROJECT NARRATIVE The heart is divided into atrial and ventricular chambers that work together to drive circulation, yet have unique functional attributes. The genetic pathways responsible for creating and stabilizing the distinctions between atrial and ventricular cell types are not well understood. Identification of the factors that maintain the differences between the atrium and ventricle will inspire new strategies for chamber-specific differentiation of pluripotent cells for therapeutic purposes and will improve our comprehension of the causes of common cardiac birth defects.